Injectable Fibrous Scaffolds for Meniscal Repair

Project Summary/Abstract
The meniscus is an important load-bearing structure that protects the underlying articular cartilage and thus
reduces the incidence of osteoarthritis (OA). Unfortunately, it has limited healing capacity in adults, so tears
often require surgical treatment. Current treatments include partial meniscectomy; however, removing part of
the meniscus exposes the cartilage and the extent of removal correlates with the magnitude of cartilage
degeneration. Unlike adult menisci, fetal and juvenile menisci exhibit intrinsic repair, which reduces the rate at
which children present with meniscus tears. Thus, tissue engineering approaches that recapitulate features of
younger menisci may provide novel approaches to treating meniscus tears. Multi-fiber scaffolds, whose
porosities are tailored to mimic low density fetal extracellular matrices (ECM), have previously been developed
that deliver multiple factors to promote initial healing. However, these rigid electrospun scaffolds have reduced
control over individual fiber components and cannot be delivered arthroscopically. This proposal targets these
impediments by utilizing a post-processing strategy in which a scaffold is fabricated out of fragmented fibers
that can be injected into a defect, reconstructed after injection, and stabilized with light. By combining different
fiber populations, this assembly permits the individual tuning of various released factors by way of tuning
different fiber degradation rates. The proposed scaffold will release a nuclear softening agent (Trichostatin A
‘TSA’) over several days, further mimicking the softer nuclei of fetal menisci compared to adult, and a
chemotactic agent (connective tissue growth factor, CTGF) over several weeks. These two factors are
expected to synergistically promote cell infiltration and ECM deposition into the scaffold. To demonstrate the
translational capacity of this material, three Aims will be conducted. Aim 1 will be geared towards fabricating
the material and demonstrating scaffold biofactor release activity individually and when released
simultaneously in vitro. Scaffold fiber components will be tailored to have precisely tuned kinetics. Aim 2A will
demonstrate the efficacy of the developed fragmented multi-fiber assembly (FMA) in a subcutaneous rat
model, thus confirming that the factors released continue to promote cell migration and ECM deposition within
an in vivo environment. Aim 2B will involve insertion of the FMA into a meniscus defect site in Yucatan
minipigs. This large animal pilot study will demonstrate that the designed material stays within its injection site
and that it integrates with the surrounding meniscus on a cellular level. Thus, this sub-Aim will set the
framework for future studies assessing the efficacy of this and other proposed tissue engineering approaches
in a large animal model of meniscus tears. Successful completion of these Aims will bypass current
impediments to implementing fibrous scaffolds clinically, thus providing an alternative treatment option for
repairing the meniscus.

Public health relevance
Project Narrative Meniscal defects occur frequently in adults, with tears occurring in at least 60 out of every 100,000 patients. However, the meniscus lacks native healing capacity, and severe tears are treated through removal of meniscal tissue via partial meniscectomy. The proposed research seeks to build a fragmented multifiber assembly scaffold to promote tissue regeneration which will provide a critical step towards bringing tissue engineering approaches that promote meniscal healing closer to clinical applications.